Innovative Deep Phenotyping of African Americans at Risk for Alzheimers disease

PROJECT SUMMARY
A critical gap in Alzheimer’s disease (AD) and Alzheimer’s disease related disorders (ADRD) clinical research
is the vast under-under-representation of Black/African American (AA) older adults. It is well-documented that
AD+ADRD is more prevalent in AA individuals relative to white individuals of European ancestry. Early
detection of AD+ADRD is critical for clinical trials aiming to develop optimal therapeutics. Without adequate
representation of AA in cognitive and biomarker studies examining the earliest changes in AD+ADRD, the
diagnostic, prognostic, and clinical utility of promising biomarkers and their effects on cognition cannot be
established. Therefore, there is a pressing need to include and deeply phenotype AAs using novel cognitive
and biomarker assessments that consider the multiple co-morbidities identified in this population.
Study location has been identified as one of the most prevalent enrollment barriers for AA older adults. This
current research proposal leverages our vast expertise in conducting home-based assessment to evaluate
clinical and neuropsychological status with equipment that we place within the home. Importantly, we will
provide door-to-door transportation for MRI and amyloid PET imaging studies that we have successfully
employed to recruit and retain culturally diverse older adults including AA, with and without cognitive
impairment into biomarker studies. This will facilitate a user-friendly and effective approach that supports the
engagement of AA older adults. Other important and innovative aspects of our proposed study include: a) the
use of our novel Cognitive Challenge Tests (CCTs) that employ sensitive and specific cognitive assessment
paradigms that have been associated to biomarkers of AD and neurodegeneration, and have been validated
for use in AA older adults with and without Mild Cognitive Impairment (MCI); b) use of state-of-the-science
plasma-based markers of AD and neurodegeneration that leverage extremely sensitive SiMoA technology;
c) we will uniquely relate our novel CCTs at baseline and longitudinally to changes over time in serially
collected plasma biomarkers (e.g., p-tau181, p-tau217, NfL, GFAP), d) comparison of plasma markers of AD and
neurodegeneration with amyloid PET imaging and extra-cellular free water diffusion as well as
neurodegenerative changes on MRI; e) accounting for the comorbidity of common chronic conditions in
the AA population, we will obtain sensitive measures of cerebrovascular disease, inflammation, diabetes and
metabolic risk, as well as chronic kidney disease; f) structural and social determinants of health will also be
assessed. The deep phenotyping of 270 non-Hispanic AA older adults in the proposed research study
and our resource sharing plan will accelerate efforts to gain critically needed knowledge of AD+ADRD
in a seriously underrepresented AA group. The data obtained will promote the reproducibility of this work in
extant databases that include AA and can facilitate comparison of findings with non-AA samples. This
important cohort will continue to be followed throughout the funding period and beyond.

Public health relevance
PROJECT NARRATIVE Black/African American (AA) older adults are vastly underrepresented in Alzheimer’s disease (AD) research despite the high prevalence of the disease in this population. This novel and innovative study will reduce prevalent barriers to participation by implementing home-based assessment and blood collection, provide technology, and facilitate door-to-door transportation services to MRI and amyloid PET imaging facilities. Novel cognitive assessment using our Cognitive Challenge Tests (CCTs) and the deep phenotyping proposed including state-of the-science blood-based biomarkers of AD and neurodegeneration using advanced Single Molecule Array (SiMoA) technology, MRI and PET neuroimaging, and examining the potential contributions of common co-morbid conditions (e.g., cerebrovascular disease, diabetes, and chronic kidney disease, etc.) and social determinants of health will answer important questions regarding how our novel CCTs map onto sensitive biomarkers for the early detection of preclinical and prodromal AD among AA individuals.